Activation of endogenous progenitors via a nanoparticle-conjugated fibrous system to enhance meniscus repair

Project Summary
Meniscus
Meniscus
initiation.
therapy
basic
novel
Previous
located
maintain Using a
Gli1-CreER driven Hh reporter mouse line, we recently found that Gli1-labeled cells contribute to the
development of the meniscus horns from 2 weeks of age. In adult and aged mice, Gli1+ cells were localized to
the superficial layer of anterior and posterior meniscal horns, and gradually decreased in number during aging.
In vivo, these cells co-expressed known markers of mesenchymal progenitors as well as the lubricant Prg4. In
culture, meniscal Gli1+ cells possessed high progenitor activities, such as proliferation, migration, and
differentiation, under the control of Hh signal. Using an in vivo mouse meniscus injury model, we showed a
rapid expansion of Gli1-lineage cells at the injury site of anterior horn. Ablation of these Gli1+ cells prior to
injury slowed the meniscus repair process. Strikingly, intra-articular injection of the Hh activator,
Purmorphamine (Pur), following injury accelerated meniscus repair and attenuated OA progression. Based on
these data, we hypothesize that the Hh/Gli1 pathway can be therapeutically targeted to treat meniscus injury
tears are the most common injury to the knee, affecting both young and old populations.
healing is limited, however, and loss of function leads o cartilage loss and osteoarthritis OA)
Current clinical treatment is palliative, and does not restore function, and no disease modifying drug
is available for the t reatment of meniscus injury. Thus, there is a critical need to better understand the
biologic mechanisms and pathways regulating meniscus homeostasis and repair in order to develop
therapeutics. Mesenchymal progenitors play a critical role in tissue maintenance and regeneration.
studies have demonstrated the existence of mesenchymal progenitors in the meniscus, with most
within the superficial layer. Hedgehog (Hh) signaling is one of a few fundamental pathways that
adult stem and progenitor cells in various organs and can activate these cells post injury.
t (
and prevent OA development via the mobilization of endogenous meniscus progenitors.
work
design
Aims
evaluate
scaffold-mediated
The objectives of this
are to understand the role of this novel signaling pathway in meniscus homeostasis and repair and to
a novel drug delivery system to enhance meniscus repair by locally targeting t his pathway. Our specific
are to: 1) determine the function of Hh signaling in meniscus development and repair; 2) synthesize and
a nanoparticle (NP)-conjugated fibrous delivery system for meniscus repair; 3) Assess Pur-NP
repair in a large animal model of meniscus injury.Small (mouse) and large (minipig) animal
models, and complementary experimental tools will be utilized to develop and translate this new therapy.
multidisciplinary
successful, this work will
healing
Our
team has worked together to generate the exciting preliminary data supporting this proposal.
provide a novel therapeutic scaffold that mobilizes meniscus progenitors to improve
of tears that are otherwise considered irreparable.
If

Public health relevance
Project Narrative Meniscus tears are the most common injuries of the knee, and can lead to osteoarthritis in both young and aged populations. By taking advantage of multiple animal models, this project will investigate a novel signaling mechanism in meniscus metabolism and design an innovative drug delivery therapy to treat meniscus injury and thereby prevent osteoarthritis progression. Information garnered from these studies will be important for advancing our knowledge of joint biology and designing novel therapeutic strategies for meniscus repair.